Bioinformatics and Pathways Core

Abstract
This Developmental Biology Phase II COBRE Bioinformatics and Pathways Core (BPC) will provide
dedicated bioinformatics and statistical support for all Junior Investigators and Pilot Project Investigators. In
particular, we will help with processing, quality control, analysis and interpretation of high-throughput
sequencing experiments such as RNA-seq, ChIP-seq, and genomic analyses. Additionally, the BPC has a
dedicated Ph.D.-level statistician who will provide continuous statistical support, both in the design and
interpretation of experiments. We have extensive experience in the effective use of state-of-the-art
bioinformatics methods and software, as well as a track record in developing novel methods to help interpret
experimental findings. We will also work proactively with the Junior Investigators to identify how informatics
approaches can help their research, and develop new informatics resources accordingly. The BPC will help
and support COBRE investigators as they submit their grants for independent research funding, both in
preparation of the relevant sections on data analysis and statistics, as well as in post-award analyses. The
BPC is led by Dr. Jonathan Wren, a bioinformatician with 128 peer-reviewed publications and 14 years of
experience, and two Ph.D.-level scientists on staff. Our top priorities are to continue to build our bioinformatics
infrastructure to help Junior Investigators and Pilot Project Investigators with data analysis, data interpretation
and identification of promising new experimental leads.